Efficacy of Brief Interventions to Reduce Comorbid Alcohol and Cannabis Misuse and Sleep Impairment in Young Adults

PROJECT SUMMARY/ABSTRACT
This application evaluates an integrated brief intervention to reduce alcohol and cannabis use and
consequences and improve sleep among young adults (YA) with comorbid heavy episodic drinking (HED),
cannabis misuse, and sleep impairment. HED in YA is an important public health problem; consequences
include accidental injury and death, academic/work problems, unsafe and unwanted sex, and development of
alcohol use disorders. Many YA with HED also use cannabis and experience increased harm as a result. Sleep
impairment is common and problematic among YA, identified as one of 5 leading barriers to academic success
for students and an important risk factor for mental health problems and suicide in YA. More than 75% of YA
report frequent daytime fatigue, 27% extreme distress related to sleep problems, and more than 1 in 4 are at
high risk for insomnia. Alcohol use has been linked to insomnia in adolescent, YA, and older adult populations,
with bidirectional causal links between alcohol use and impaired sleep. Comorbidity of HED and sleep
impairment is associated with increased consequences of alcohol use and exacerbates risk of accidents
(including automobile accidents), impaired decision-making, and work and academic difficulties. Similar
bidirectional relations exist with cannabis use and sleep, and co-use of these substances may be particularly
harmful for sleep. Despite these risks, alcohol and cannabis prevention programs rarely target sleep directly,
and the majority of YA sleep interventions either focus on sleep hygiene broadly in the absence of specific
strategies to improve sleep or reduce alcohol/cannabis use, or have insufficient sample size and duration to
truly evaluate impacts on sleep or related comorbid alcohol or cannabis use. Building on our successful R34
intervention development project, the current study addresses these gaps by evaluating efficacy of integrating
a brief sleep intervention (BBTI) with an efficacious brief alcohol and cannabis intervention (BASICS/Cannabis
BMI) to increase magnitude and duration of effects on sleep and alcohol and cannabis misuse among a
diverse community sample of YA with comorbid insomnia, HED, and cannabis use. Given bidirectional
influences between sleep impairment and alcohol/cannabis misuse leading to significant public health
challenges for this population, an efficacious integrated treatment is imperative. Impact will be evaluated in a
RCT comparing efficacy of telehealth-delivered, integrated BASICSSLEEP to BASICS/BMI only (BASICS+),
BBTI only (SLEEP), and Attention control (AC). Surveys and daily diaries will assess alcohol, cannabis, and
sleep at baseline, post-tx, 3-, 6-, 12-, and 18-months. Specific aims are: (1) Evaluate comparative efficacy of
BASICSSLEEP, BASICS+, and SLEEP in reducing alcohol/cannabis use and consequences and improving
sleep; (2) Evaluate moderators of efficacy for integrated and monotherapies; and (3) Use diary data to evaluate
temporal sequencing of effects and duration/decay over time. Findings will remedy important gaps in the
literature and result in a scalable, accessible new resource to address this important and costly comorbidity.

Public health relevance
PROJECT NARRATIVE Alcohol and cannabis misuse are associated with significant harm in young adult populations, including all three leading causes of death (accidents, suicide, homicide). Sleep impairment is also common and costly among young adults, and research indicates significant comorbidity among alcohol misuse, cannabis misuse, and sleep impairment with evidence of bidirectional causal relationships that can exacerbate related harms. The current application uses a rigorous and efficient trial design to test an integrated brief alcohol, cannabis, and sleep intervention in comparison to two monotherapies (for alcohol/cannabis misuse and for sleep) to address this important and often overlooked comorbidity among young adults.